Analysis Core-MCUAAAR

Analysis Core Abstract
The overarching goals of the Analysis Core (AnC) are to support innovative investigations into the processes
and mechanisms underlying health inequities and disparities, and to develop interventions to improve the
health and well-being of older African Americans. There are four objectives of the AnC: 1) provide junior
research investigators and MCUAAAR faculty the exposure and methodological tools necessary for conducting
successful pilot projects and supporting Center activities; 2) apply a biopsychosocial life-course framework to
generate novel measurement strategies and state-of-the-art techniques for measurement, data collection and
analysis; 3) facilitate and promote cross-institutional and interdisciplinary collaborations between NIA/NIH
Centers and Institutes and the newly-formed MCUAAAR Internal Resources Group (IRG) across the three
leading research universities in Michigan; and, 4) develop and test novel methodologies for addressing ethnic
minority population health disparities. The AnC will work with the Administrative Core (AC) and leverage the
MCUAAAR Research Education Component (REC) and Community Liaison and Recruitment Core (CLRC)
Participant Pool, as well as other community and institutional resources, to synergistically enhance the
activities of the overall Center. The AnC builds on two principle strengths, an outstanding faculty that
represents a breadth of methodological and analytical expertise, and access to exceptional inter-institutional
data resources, computational capability, and research infrastructure (e.g. the HRS and Michigan Institute for
Data Science (MIDAS)). These resources contribute to a multi-level, integrated approach to support and train
junior investigators, and to develop the strategies needed to successfully investigate the biological,
psychological, and social processes driving disparities within a life-course framework. The depth and breadth
of the AnC faculty ensures that MCUAAAR investigators will have access to resources and expertise in
measurement, statistical methods, sampling techniques, complex survey design, qualitative data collection and
analytic methods, mixed methods strategies for new and existing data, genetic and epigenetic analysis, and
information science for “big” data. There are three specific aims: 1) Provide the leadership and structures to
support MCUAAAR research investigators and MCUAAAR faculty; 2) Apply a biopsychosocial approach to
develop novel strategies in study design, data collection (qualitative and quantitative), measurement tools, and
analytic techniques for investigating the health of African American over the life-course; and, 3) Work with
other NIA/NIH Centers and Institutes through the (IRG) to develop and test novel methods and analytic tools.